REGULATION OF INHIBITION IN HIPPOCAMPUS

Depression of GABAergic inhibitory postsynaptic potentials (IPSPs) represents an important regulatory mechanism in mammalian brain. The present project will test the hypothesis that postsynaptic increases in intracellular calcium concentration ([Ca2+]i) resulting from physiological processes in hippocampal pyramidal cells depress GABAA IPSPs. Current-clamp and whole-cell voltage-clamp recordings will be made in the hippocampal slice preparation. The following specific aims are proposed: 1) To determine if increased [Ca2+]i in pyramidal cells depresses GABAA responses and GABAergic IPSPs and IPSCs. Preliminary data suggest that this is true. 2) To determine which of several possible sources of Ca2+i are effective in doing so. Voltage-dependent Ca2+ channels, ligand-gated Ca2+ influx, Ca2+ release from intracellular stores and ion exchange mechanisms will be investigated. 3) To identify the intracellular biochemical system or systems responsible for the Ca2+ effects. 4) To investigate the short- and long-term functional implications of the Ca2+ effect. Regulation of GABAergic IPSPs by Ca2+i implies that an important positive feedback interaction may exist between the GABAA system and the mechanisms of Ca2+ influx (e.g., voltage-dependent Ca2+ channels, NMDA- mediated responses, etc.) often influenced, directly or indirectly, by this system. This work is directly relevant for understanding the neurophysiology of epilepsy and of hippocampal long-term potentiation.